Mapping and Exploiting the Internal Wiring of Structurally Dynamic Phosphatases

PROJECT SUMMARY/ABSTRACT
Proteins recognize signals from their cellular environments and respond by altering their function in a
phenomenon known as allostery. However, the atomic-level mechanisms underlying allostery, including the
key role of shifts in protein conformational ensembles, remain poorly understood. In particular, we lack an
understanding of how allostery differs between related proteins, such as the biomedically important Protein
Tyrosine Phosphatases (PTPs), which all share a common ground-state 3D structure yet exhibit many distinct
cellular roles and human disease associations. Research in my lab focuses on developing experimental and
computational methods to unveil allosteric mechanisms from protein conformational ensembles, and applying
these methods to decipher and exploit differences in allosteric wiring between PTP family members. We have
pushed the frontiers of experimentally modulating protein conformational landscapes using multidataset X-ray
crystallography and developed algorithms to model coupled protein conformational heterogeneity. Using these
tools for two distinct PTPs, we have revealed coupled conformations that link distal sites to the dynamic active
site and new small-molecule ligands at promising allosteric sites. With renewed funding for this award, we will
work to understand how allosteric wiring differs across the larger family of PTPs, and how such differences can
be exploited to modulate the functions of specific individual PTP drug targets. We will develop and apply an
expanded repertoire of avant-garde X-ray crystallography experiments and computational tools for modeling
and biasing protein ensembles, and use them to elucidate allosteric circuitry that is unique to specific PTP
enzyme architectures. To target these allosteric weak points in selected PTPs of high biomedical interest, we
will leverage methodological improvements in high-throughput crystallographic ligand screening and
complementary solution biophysics methods like high-resolution HDX-MS to identify and characterize novel
small-molecule allosteric modulators. Overall, the proposed research will open new doors for the challenging
task of achieving specific functional modulation of individual PTP drug targets, and will have broader
implications for our understanding of the mechanisms by which evolution has sculpted a menagerie of
structurally dynamic, functionally distinct enzymes given the constraints of modular structural building blocks.

Public health relevance
PROJECT NARRATIVE Phosphatases are a family of proteins in human cells that play key roles in orchestrating healthy physiology. However, different phosphatases are dysregulated in different diseases, including metabolic disorders such as diabetes and obesity, neurological diseases such as Alzheimer’s, autoimmune diseases, and cancer. This proposal aims to unravel the molecular basis of differences between phosphatases, which will help facilitate the future development of therapeutics that correct dysfunction associated with specific phosphatases to counteract a wide range of human diseases.